Confocal microscope for Cornell BRC Imaging Facility

Project Summary/Abstract
This proposal requests funds for a Zeiss LSM980 confocal microscope for the Cornell Biotechnology Resource Center (BRC)
Imaging Facility. Currently the imaging facility has two inverted confocal microscopes that are heavily used (average 58
hrs/week for the past two years). The 13-year old Zeiss LSM710 has become obsolete. Though it is still functioning, Zeiss
will no longer guarantee repairs or parts for it. A new confocal microscope is critical to ensuring imaging capacity for our
many NIH researchers at Cornell on the Ithaca campus. Additionally, the requested confocal microscope will have
capabilities that are not currently available on campus, including the fast Airyscan module, the AI sample finder and near-
IR (NIR) detection capabilities. We are requesting a non-linear optical (NLO) capable unit, and will be integrating the
system with an existing multiphoton (NLO) source as well as its associated existing Zeiss beam routing and detection optics.
Data management, scheduling and billing will be accomplished using already established BRC infrastructure. Training will
be carried out by a PhD level staff scientist. The microscope will be available to all researchers on and off campus, and
will advance a broad segment of NIH-funded research programs generally by ensuring sufficient confocal capacity, and
specifically by providing new capabilities for projects requiring fast tiling at high resolution, fast intracellular dynamics,
and the ability for imaging NIR-emitting fluorophores.

Public health relevance
Project Narrative This proposal describes a request for a confocal microscope to be managed in an imaging core facility at Cornell University. The microscope will support a diverse group of NIH-funded researchers investigating a broad spectrum of biological and biomedical projects, ranging from gene regulation at the single molecule level to gut development, breast cancer and heart disease.